Computational Modeling of Mouse Forelimb Movements

Project Summary/Abstract
Mouse forelimb movements are widely studied in systems neuroscience to study healthy and injured motor
networks (e.g., after stroke or cerebellar disease). This proposal builds on our novel musculoskeletal model of
the mouse forelimb to develop free and open-source tools for the neuroscience community to extract
biomechanical features that are difficult or impossible to measure experimentally and to investigate
hypothesized control architectures with artificial neural networks and physics-based simulations. In Aim 1, we
will develop a computational model based on optimal control theory to estimate muscle activity from kinematics
and optional electromyography as state-of-the-art experimental methods can only measure from 3-4 muscles
simultaneously out of the 25+ forelimb muscles. We will also develop a tool to predict mouse reaching
kinematics and muscle activity when there is a change in the task or limb biomechanics, which could help
reduce the number of experiments with mice. The computational models will be validated with experiments of
mice reaching to different pellet locations and with different weights placed on their limbs. In Aim 2, we will
demonstrate how to use the musculoskeletal model and physics engine to extract biomechanical features and
correlate them with neural activity in motor cortex and the cerebellum. This will allow to us to test hypotheses in
motor control such as whether interaction torques are represented in Purkinje cells' activity or whether motor
cortex drives an abstract representation of the limb or a detailed biomechanical model during reaching. We will
develop in silica networks and compare and contrast them with analogous neural structures. We will show that
by modeling these artificial networks with different assumptions and architectures, we will be able to dissociate
between hypotheses in motor control, such as whether the cerebellum implements a forward model or a
control policy during motor adaptation or whether both sensory input and motor cortex exhibit rotational
dynamics during three-dimensional reaching to different pellet locations. These artificial neural networks will be
validated with empirical neural data. We will synthesize feedback controllers using these artificial neural
networks with deep reinforcement learning so that researchers can implement hypothesized control
architectures and observe the effects of neural manipulations and disturbances on the predicted kinematics
and muscle activity. We will refine our tools with end-users to ensure their ease-of-use and extensibility. A
web-based interface will be implemented allowing users to develop their code, visualize the simulations and
run optimizations on the cloud or using their own computers or servers. We will disseminate these tools with
extensive documentation, example code, online video tutorials and maintaining a forum for end-user questions
and requests.

Public health relevance
Project Narrative Mouse forelimb movements are widely studied in systems neuroscience to investigate the neural control of movement and to understand the causes of movement disorders. The proposed research is relevant to public health because the computational modeling of forelimb movements, informed by empirical data, can help reveal cause-effect relationships between neural or physiological deficits and movement disorders, which could lead to the design of more effective rehabilitation therapies, treatments and neurotechnologies.